PSYCHOLOGICAL DISTRESS AND IMMUNITY AMONG CANCER PATIENTS AT DIAGNOSIS

Assessment of psychological distress on total lymphocyte counts, mitogen induced lymphocyte proliferation, and natural killer cell activity in normal women and women with gynecological malignancy.